Evaluating the relationship between immune checkpoint inhibitors and osteoarthritis

Project Summary/Abstract
The major goals of this proposal are to: 1) Determine whether hip osteoarthritis (OA) is a risk factor for
developing inflammatory arthritis (IA) due to immune checkpoint inhibitors (ICIs). 2) Evaluate whether
preexisting hip OA progresses more quickly in patients exposed to ICIs as compared to other patients with
cancer. ICIs have improved outcomes for a variety of malignancies, but also cause immune related adverse
events (irAEs). ICI-induced IA is the irAE most likely to be encountered by rheumatologists. ICI-induced IA
causes significant morbidity, is clinically heterogeneous, and can persist after ICI cessation. Despite its impact
on patients, clinical risk factors for ICI-induced IA are not well defined. The proposed project will utilize a cohort
of well characterized patients treated with ICIs and CT imaging already obtained as a part of cancer clinical
care to address the question of whether hip OA is a risk factor for development of ICI-induced IA. This project
tests the hypothesis that an abnormality in the microenvironment of one joint can lead to a systemic
inflammatory response that in turn affects other joints in the setting of immune activation by ICIs.
Understanding risk factors for development of IA will allow for risk stratification of patients prior to therapy,
differential monitoring, and potentially allow for trials of preventive therapies. The proposal will also evaluate
progression of hip OA with serial CT scans in patients treated with ICIs and other cancer patients treated with
different therapies. Patients on ICI therapy can experience an increase of symptoms of preexisting OA
sometimes termed “activated OA”. Whether this increase in symptoms is related to increased progression on
imaging is unknown. This study will determine if progressive OA is likely to be a major cause of morbidity and
functional limitation in long-term survivors from cancer treated with ICIs. In sum, the proposal will answer
important questions about the relationship between ICI therapy and OA using radiographic data from CT scans
obtained through routine clinical care, thereby generating no additional cost or radiation exposure for patients.

Public health relevance
Project Narrative This project addresses the relationship between immune checkpoint inhibitors, a type of cancer therapy, and osteoarthritis. The proposal will determine if osteoarthritis is a risk factor for immune checkpoint inhibitor- induced inflammatory arthritis. The proposal will also evaluate whether there is increased progression of osteoarthritis on imaging in patients treated with immune checkpoint inhibitor therapy.